Recruiting and retaining participants from disadvantaged neighborhoods in registries

Abstract of Parent Research Project
Alzheimer’s disease (AD) and related disorders (ADRD) research represents a major national investment. ADRD
clinical research faces delays and risks to internal and external validity resulting from challenges to efficient
accrual, especially inadequate inclusion of populations at increased risk for disease due to social determinants
of health. Recruitment registries are tools to accelerate accrual in ADRD research. Registries are repositories of
potentially eligible individuals who have consented to be contacted about studies, reducing the need for serial
recruitment by enabling bolus enrollment of ready cohorts. Few data address essential questions about registry
design, conduct, and effectiveness in aiding ADRD research recruitment. How best to recruit and retain
participants to registries and whether registries can address the urgent need to diversify clinical research
samples are unknown. Furthermore, how registry samples compare to other research populations has not been
investigated. This proposal investigates traditional and modern approaches to registry recruitment and asks
critical questions about inclusion of participants from underserved neighborhoods and registrant retention. Given
that registries are, by definition, convenience samples, we also aim to quantify the bias associated with these
recruitment tools and develop methodology for addressing this bias. This project will produce essential
information about resource utilization in recruitment registries and provide critical guidance for the field about
how best to use these important tools.

Public health relevance
Project Narrative Alzheimer’s disease and related disorders (ADRD) research represents an area of major national investment. But ADRD research faces delays and risks to internal and external validity resulting from consistent challenges to efficient and generalizable accrual. Recruitment registries are tools to address these challenges by establishing large repositories of individuals who are potentially eligible and willing to participate in research, expediting discovery. This proposal will provide researchers with critical evidence to instruct methods to diversify registries by including people from the most disadvantaged neighborhoods and addressing sample bias in these unique recruitment interventions.